Building a Wide-field, High-resolution Histotomography Resource for Biology

Every living organism is made up of cells that are organized into tissues, whose micron-scale features define
normality and disease. These principles inspire the long-term goal of this project: to enable the quantitative
characterization of the Geometry of Life and Disease as a foundation for a comprehensive and integrative
understanding of how genes, environment and disease determine anatomical and microanatomical phenotypes.
Ideally, the effects of genes and environment on anatomical and microanatomical phenotypes can be assessed
across the whole organism. We understand the cellular basis of disease as a result of histology's representation
of all cell types and two centuries of application to clinical medicine. However, histology is 2-dimensional,
qualitative, subject to sectioning artifact, and samples only ~1-2% of specimens. To facilitate anatomically
comprehensive phenotyping across whole organisms, we have developed a unique, state-of-the-art 3D modality
(histotomography) based on the principles of X-ray tomography and the creation of large-field, high resolution
instrumentation for tomographic, synchrotron-based beamlines. The ability to conduct histological assessment
in a whole organism in 3 dimensions promises revolutionary advancements on numerous fronts. We propose to
establish the groundwork for large-scale access to synchrotron microCT for biology, including a pilot imaging
facility at the Lawrence Berkeley National Laboratory (LBNL) and then at Argonne National Laboratory (ANL) for
histotomography, to initiate access to visualizations and histotomograms of whole, centimeter-scale model
organisms and tissues, and to establish a basic set of web-based visualization and cross-referencing tools for
the scientific community.
Cloud-based dissemination of raw and reconstructed image data will be piloted at the National Energy Research
Scientific Computing Center operated by LBNL or Argonne Leadership Computing Facility (ALCF) at ANL, to
enable users to advance their educational, functional, and scientific goals. Notably, the proposed groundwork
will comprise a foundation for computational phenotyping that is more comprehensive, objective, precise, and
statistically validated. Broad accessibility to microanatomical resources would enable valuable, new means of
model validation, reproducibility, and discovery, and provide a new foundation for a more comprehensive
understanding of genetic, molecular, and cellular function in the study of normal biology and disease. We expect
the proposed work to lead to unexpected research observations, improved clinical outcomes, enhanced
robustness and reproducibility of biomedical research, and enhanced sustainability and human health by
advancing the quality and comprehensiveness of global monitoring of environmental toxicity and climate change.

Public health relevance
We aim to plan and develop rapid imaging instrumentation deployment in DOE, software workflows, data sharing and visualization mechanisms, and educational software towards broad community access to a state- of-the-art, 3-dimensional form of histology, X-ray histotomography, that enables the study of all cell types in whole cm-scale organisms and tissue samples. The proposed work includes pilot studies to image samples at an unprecedented combination of 5 mm field-of-view (FOV) with 0.5 μm isotropic resolution at Lawrence Berkeley National Laboratory and 10 cm FOV/0.7 μm resolution at Argonne National Laboratory, that will be paired with rapid access to web-based instructional material, to facilitate web-based image and file access, and to set the stage for community-based generation of tools for computational tissue phenotyping. The positive impacts of accessible histotomography are expected to advance our understanding of cells and tissues in organismal context, including the study of genetic, environmental, and disease determinants of phenotype, and facilitate the development of shared computational tools across disciplines in biology, toxicology, biosphere monitoring, and disease diagnostics.